06 Prevention and Control Program

PREVENTION AND CONTROL PROGRAM (PCP): PROJECT SUMMARY
Cancer continues to pose a major threat to public health nationally and in the Siteman Cancer
Center (SCC) catchment area. The pioneering transdisciplinary and translational research within
the SCC Prevention and Control Program (PCP) is aimed at reducing the cancer burden and
spans from prevention to early detection through survival. Adding to the robust depth and breadth
of PCP expertise, research within the program spans from the cell to society and includes basic
science, large data analytics, clinical and community-based intervention and implementation
research, as well as policy research in clinical and community settings. Building on PCP’s
impactful and practice-changing research from the past five years and based on key needs in the
SCC catchment and beyond, the PCP will address the following specific aims: Aim 1. Reduce the
impact of tobacco use and resultant cancers by conducting research across the continuum, from
prevention to detection and cessation. Aim 2. Reduce cancer through rigorous research in
cancer prevention and control. Aim 3. Advance dissemination and implementation science
methods to reduce the cancer burden. PCP’s research priorities are responsive to and reflective
of the catchment area. Cigarette smoking rates are above average in our catchment; lung cancer
rates are above the national average. Similar to the rest of the nation, we observe delays in the
implementation of evidence-based practice across many settings. Our unique catchment includes
parts of Missouri, which has the lowest cigarette taxes in the nation and lacks Medicaid
expansion, and parts of Illinois, which has a more stringent cigarette policy and expanded
Medicaid. Together this results in a microcosm in which to study tobacco use, cancer rates, and
implementation science. PCP membership includes experts in disciplines such as psychology,
epidemiology, biostatistics, economics, public health, clinical medicine, and basic science. The
program has 38 members from eight departments and two schools at Washington University. The
PCP is supported by $8.3 million in funding, of which $5.1M is from NCI and $2.4M is other
cancer-focused peer-reviewed. In the current project period, PCP members published 1,096
manuscripts, of which 25% and 25% represent inter- and intra-programmatic collaborations,
respectively. In 2018, the PCP had 7,355 total enrollments into clinical studies, of which 38%
were interventional. With these assets and this record of past achievement, the PCP is poised to
make substantial impacts on public health and clinical practices and policies related to cancer
control that will benefit the health of the population.